Interdisciplinary Network on Rural Population Health and Aging

The rural U.S. is sick, old, and in decline – or is it? This familiar narrative of “left behind” rural people and places
tells only one part of the story of rural America – the most pessimistic one. Although it is true that rural areas are
home to disproportionate shares of older and sicker people, and rural-urban disparities in health and longevity
are large and growing, it is also true that some rural places are thriving. New approaches to researching rural
health and aging are needed, recognizing that rural America is not monolithic; it contains both resilient and
vulnerable places, and its challenges are multilevel and multidimensional. Building on the successes and lessons
of its last five years, the Interdisciplinary Network on Rural Population Health and Aging (INRPHA) will spark and
sustain new collaborations that will advance research on the factors affecting the health and wellbeing of rural
working-age and older adults within the context of prevailing demographic trends, slow-moving macro-level
stressors, and contemporary public health and environmental shocks. In so doing, the Network will inform new
approaches to improve wellbeing, health, and functioning in rural America. Our proposal is both significant and
novel because INRPHA’s activities will a) be national in scope and attend to differences in health and aging
across different rural regions, economies, population change patterns, and demographic groups; b) illuminate
not only rural-urban, but also within-rural variability to better understand variation in outcomes, including what
we can learn from thriving rural communities; c) elucidate mechanisms across the life course that are driving
observed rural-urban and within-rural health and aging outcomes, trends, and disparities; and, d) leverage ex-
isting NIH-funded data resources that can be used to advance rural population health and aging research. Lev-
eraging the institutional assets within the proposed Network’s five lead universities – U Minnesota, Penn State,
Syracuse U, Mississippi State, and U Colorado, Boulder – INRPHA’s aims are to (1) conduct and support re-
search that will enhance understanding of the multilevel and multidimensional causes of health, functioning, and
mortality outcomes, trends, and disparities among U.S. rural working-age and older adults, with a particular focus
on within-rural heterogeneity; (2) strategically grow the Network by expanding existing membership to include
scholars from relevant disciplines and who represent various topical and methodological perspectives; (3) pro-
vide development and training opportunities through pilot grants, structured mentoring, topical and data work-
shops, and regular network meetings, including efforts to promote members’ knowledge and use of existing NIH-
funded datasets conducive to conducting robust rural-urban and within-rural research; and, (4) advance mem-
bers’ dissemination of research findings through training and support of academic articles and policy briefs and
through public webinars to expand access to knowledge that will inform research, policies, and programs related
to rural population health and aging. INRPHA’s activities emphasize developing a sustainable foundation to sup-
port continued innovative, publicly accessible, and impactful research on rural population health and aging.

Public health relevance
Project Narrative On average, rural Americans die younger and spend more of their lives in poor health than their urban peers – disparities that have been growing for the past 40 years. However, rural places are not all the same, and while some rural areas face significant challenges related to living long and healthy lives, others are thriving and may offer lessons that can improve health and longevity in struggling rural communities. The Interdisciplinary Network on Rural Population Health and Aging (INRPHA) brings together scholars from multiple disciplines, institutions, and topical interests to advance knowledge on the complex factors affecting the health and wellbeing of rural working-age and older adults through various activities, including: regular meetings, workshops, and working groups; pilot grants to stimulate new research; mentoring of junior scholars; and dissemination of findings to academic, policy, and public audiences through presentations, academic publications, public research briefs, and more.